Advancing the Study of Stroke in Women Through the Integration of Basic, Clinical, and Socioeconomic Perspectives

Project Summary/Abstract
Despite lower age-specific rates of stroke in women compared to men, stroke has a disproportionate impact on the lives of women. The objective of this conference is to bring together multidisciplinary experts, and early career and underrepresented investigators to detail the current state of the science related to stroke in women, discuss knowledge gaps in the field, and propose future research initiatives that can be supported by this group and others moving forward. The conference will focus on three inter-related themes relevant to stroke in women: 1) social and economic circumstances of women and men and the impact on stroke, 2) mechanisms of sex differences in stroke as determined by pre-clinical research studies, and 3) increasing enrollment of women in stroke-related randomized clinical trials. The conference will expand on previous collaborations and networking initiated by the multidisciplinary, ad hoc working group on stroke in women -- Prevention and Outcomes in Women Enhancing Stroke Support (PROWESS). The conference has been designed to support junior faculty and individuals from underrepresented groups working in the area of stroke, sex differences, and women, with the goal of assisting them to develop focused hypothesis-driven research relevant to stroke in women. The conference will result in the dissemination of a summary statement and the development of collaborations to advance future research.

Public health relevance
Project Narrative Studies consistently show that women have worse recovery, poorer function, and lower quality of life following stroke than men do. This conference will bring together multidisciplinary experts, early career and underrepresented investigators to describe current science related to stroke in women and discuss knowledge gaps. It will propose new future research projects that can be done to make improvements in stroke prevention and recovery in women.